Mechanisms of corneal stromal activation during regeneration and fibrosis by exosomes

SUMMARY
Corneal scarring (or fibrosis) is known to cause visual impairment in moderate to severe wounds, and with no
single effective therapy for either the prevention or treatment, the need for new tools to treat and reduce the
risk of scarring is urgent. Cell-cell communication is a vital component for the cornea that encompasses
homeostasis, regeneration, and fibrosis. We have shown that the wound-healing mechanisms of corneal
epithelial cells are comprised in their secretome, with extracellular vesicles (EVs) being a key vector. During
EV production, the EVs selectively engulf a part of their parental cell and become enriched in a repertoire of
bioactive cargo (e.g., proteins, lipids, and RNAs). We recently reported that human corneal fibroblasts (hCF)
treated by TGF-β1 increased expression of fibrotic markers that established a fibrotic matrix, unlike TGF-β3
(anti-fibrotic). Also, our data suggests that EVs derived from human corneal epithelial cells (hCE-EV) can
trigger hCF differentiation, and the proteome of hCE-EV containing TGF-β1 or -β3 could be a driving
mechanism that could contribute to the mechanistic action of corneal scar formation. Although, despite the
wound-healing and corneal stromal activation capacity of hCE-EVs, our understanding of their bioactive
properties and molecular mechanisms for such effects remains unclear. In this proposal, we hypothesize that
the EV subsets, hCE (TGF-β1KD/-β3KD)-EVs, will trigger corneal myofibroblast differentiation to generate an
activated stromal microenvironment that supports fibrotic healing. We propose the following Aims to test this
hypothesis: Aim 1) Modulate and characterize hCE-EV subsets; Aim 2) Define stromal activation capacity of
hCE-EV subsets in 2D and 3D models in vitro; and Aim 3) Determine how hCE-EV subsets effect corneal
scarring in vivo. Relevance to Public Health—Collectively, this proposal will provide important insight for hCE-
EV biology and corneal fibroblast-target cell interaction, which can be leveraged to develop novel EV-based
therapies for the prevention and treatment of corneal scarring.

Public health relevance
NARRATIVE Currently, there are no effective tools for preventing or treating corneal scarring, which is a complication that potentially occurs with ocular injury, trauma, and/or surgery, and may result in decreased quality of life and possibly blindness. Extracellular vesicles (EVs), which contain cargo (e.g., RNA, protein, and lipids), are released by the corneal cells, and those released by the corneal epithelium can trigger myofibroblast differentiation, which will cause scarring and diminish vision if they persist. In this proposal, we will identify the EV-subset that is vital for corneal stromal activation and scarring, so that we may move forward with the development of novel therapies for the prevention and treatment of corneal scarring.